The role of satellite cells in adult skeletal muscle growth and maintenance

DESCRIPTION (provided by applicant): The loss of skeletal muscle mass is of clinical importance because it is associated with increased morbidity and mortality, as well as a marked deterioration in the quality of life. A broad patient population is affected by significant losses in muscle mass including those afflicted by various systemic diseases (cancer, sepsis, HIV- AIDS), chronic physical inactivity as a result of long term bed rest, rheumatoid arthritis and limb immobilization, and sarcopenia, the age associated loss in muscle mass and strength. Satellite cells are currently an attractive therapeutic target given their stem cell characteristics and essential role in post-natal muscle growth and regeneration. What remains controversial is the necessity of satellite cells in other aspects of muscle plasticity such as hypertrophy, re-growth following atrophy and muscle maintenance with aging. In an effort to resolve this fundamental issue, a novel mouse line was created which enables the specific ablation of satellite cells in mature skeletal muscle. The Pax7-DTA mouse will be used to investigate the physiological function of satellite cells in skeletal muscle hypertrophy (Aim 1) and re-growth following muscle atrophy (Aim 2). The results from the proposed experiments are expected to provide fundamental knowledge on the function of satellite cells in adult skeletal muscle plasticity which will help define the therapeutic value of satellite cells in treating the loss of muscle mass in various clinical conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Loss of muscle, a common symptom associated with many chronic diseases, physical inactivity or aging, negatively impacts a person's quality of life, increases the susceptibility to other complications of disease and can even lead to death. Treatments designed to restore or prevent muscle loss have in part focused on using muscle stem cells referred to as satellite cells. The goal of the proposed research is to determine if satellite cells are necessary for adult muscle growth and thus, are an appropriate target for therapy for skeletal muscle loss. Relevance Loss of muscle, a common symptom associated with many chronic diseases, physical inactivity or aging, negatively impacts a person's quality of life, increases the susceptibility to other complications of disease and can even lead to death. Treatments designed to restore or prevent muscle loss have in part focused on using muscle stem cells referred to as satellite cells. The goal of the proposed research is to determine if satellite cells are necessary for adult muscle growth and thus, are an approprioate target for therapy for skeletal muscle loss. __SpecificAimsTextDelimiter__ Specific Aims There is a general consensus in the field that satellite cells are required for post-natal muscle growth and regeneration. What remains controversial is the necessity of satellite cells in other aspects of muscle plasticity such as hypertrophy, re-growth following atrophy and muscle maintenance with aging. At the center of this controversy is the inability to specifically ablate satellite cells in adult skeletal muscle. In an effort to resolve this fundamental issue, a novel mouse line was created which enables the conditional ablation of satellite cells in mature skeletal muscle. The Pax7-DTA mouse line was generated by crossing two established mouse lines, the Pax7CreER line and a Rosa26DTA line. The Pax7-DTA mouse allows temporal control of satellite cell ablation by restricting Cre- mediated activation of diphtheria toxin A (DTA) gene expression to satellite cells. The Pax7-DTA mouse was used to test the hypothesis that satellite cells are necessary for skeletal muscle hypertrophy in response to mechanical overload induced by synergist ablation. Contrary to this hypothesis, evidence showed the primary hypertrophic response, which occurred within the first two weeks and accounted for the majority of the growth (doubling of muscle mass), did not require satellite cells. After four weeks of overload, however, notable differences were observed in muscle weight and myonuclear number, suggesting continued growth and/or maintenance of the increased muscle mass may require satellite cells. Moreover, expression profiling suggested that satellite cells may be necessary for extracellular matrix homeostasis as evidenced by increased collagen expression under both resting and hypertrophic conditions in muscle devoid of satellite cells. These novel findings demonstrate the unique utility of the Pax7-DTA mouse to study the in vivo function of satellite cells in adult skeletal muscle. The following specific aims will be pursued using this powerful new model: Specific Aim 1. Quantify the hypertrophic response of adult skeletal muscle following depletion of satellite cells. The purpose of this aim is to definitively determine the role of satellite cells in different stages of muscle hypertrophy in mature mice, as well as in the maintenance of the hypertrophic state. Synergist ablation will be used to induce muscle hypertrophy of the plantaris and soleus muscles in adult mice with or without satellite cells. The efficacy of satellite cell ablation will be assessed by immunohistochemistry (IHC), Fluorescence Assisted Cell Sorting (FACS) and single fiber analyses. The effect of satellite cell depletion on muscle hypertrophy will be determined by measuring muscle mass, fiber cross-sectional area, fiber morphology, myonuclear number and fiber-type composition. Muscle function, at the whole muscle and single fiber levels, will be measured to determine if the loss of satellite cells affects the contractile properties of control and hypertrophied muscle. FACS, expression profiling and cell signaling analyses will be performed to determine if a compensatory mechanism(s), such as expansion of an alternative progenitor cell population, occurs upon satellite cell ablation at rest and during different stages of hypertrophy. Satellite cells will then be ablated at increasingly advanced age and muscle properties quantified following synergist ablation as described above to determine if there are age-associated alterations in the muscle hypertrophic response. Specific Aim 2. Determine if satellite cells are necessary for skeletal muscle re-growth following muscle atrophy. Evidence suggests satellite cells are required for the restoration of muscle mass following atrophy by replacing apoptotic myonuclei. To test this hypothesis, the recovery of muscle mass with reloading following two weeks of hindlimb suspension will be analyzed in soleus muscle with and without satellite cells. The effect of satellite cell ablation on soleus muscle at rest, during atrophy and with re-growth will be determined using the same outcome measures as described in Aim 1 and with advancing age as well. The loss of skeletal muscle mass and function observed with prolonged physical inactivity, aging and disease- related wasting leads to a deterioration in the quality of life, as well as increased risk of morbidity and mortality. It is critical to have a fundamental understanding of the physiological function of satellite cells in skeletal muscle plasticity in order to make a meaningful assessment of the value of satellite cells as the basis of therapies to treat these conditions. Acquiring this fundamental knowledge has been hampered by the inability to specifically eliminate satellite cells from adult skeletal muscle - the Pax7-DTA mouse line removes this barrier and provides a powerful new tool for the muscle plasticity field to use for the in vivo study of satellite cells. Results of this project, combined with results from ongoing satellite cell labeling and tracking experiments using the same growth models, will provide new insight into the potential utility of targeting satellite cells to promote adult muscle growth and maintenance, particuarly during aging. An additional strength of the grant is that as members of the UK Center for Muscle Biology, the broad technical expertise and resources to successfully perform all of the proposed experiments are currently in place.